Selective Targeting of the PD-1+ HIV/SIV reservoir with novel anti-PD-1 chimeric antigen receptor T cells

Project Summary/Abstract
Human immunodeficiency virus infects cells of the immune system and, if left untreated leads to the development
of acquired immunodeficiency syndrome and death. With the advent of antiretrovirals, HIV infection has turned
into a chronic infection. However, tools and therapeutics to dissect and deplete SIV/HIV latent reservoirs during
combination antiretroviral therapy (ART) to interrogate their importance in defining reservoir dynamics are limited
and are a focus of this application. Programmed cell death protein 1 (PD-1) is an immune checkpoint protein
expressed on latently infected CD4 T cells and in particular T follicular helper (TFH) cells. TFH cells reside in the
germinal centers and are enriched with replication-competent human immune deficiency virus 1 (HIV) provirus
in people with HIV. Our proposal builds upon the pre-clinical work we performed in non-human primates in which
we demonstrated that anti-PD1 chimeric antigen receptor T cells eliminated all detectable PD-1 expressing TFH
cells; the first time the elimination of this reservoir of HIV has been reported. Moreover, it also depleted memory
CD8+ T cells leading to accelerated disease progression. Here, we engineered novel CAR T cell modalities that
are either controllable through an NS3 ON switch modulated by a small molecule inhibitor (Grazoprevir; GZV) or
are a more specific CAR by integrating it into a LINK CAR platform that allows true Boolean AND gating by
targeting CD4 and PD-1. Ultimately, we will combine these T-cell engineering strategies and build CAR T cells
with higher safety and specificity, that are equally suitable for HIV cure interventions as wells as tools for CAR T
cell-mediated depletion of cell subsets in the RM model. This will allow to deplete PD-1+ T cells or PD-1+ CD4+
T cell subsets temporarily and selectively. Initially, we will optimize these new CAR modalities in adoptive transfer
experiment in uninfected rhesus macaques (RM). These experiments will show strong association of GZV
plasma levels with expansion and collapse of the CAR T cell population, which will dovetail with depletion of PD-
1+ cells when CAR T cells are expanding. We will study whether immune reconstitution occurs after temporary
PD-1- targeted deletion after cessation of GZV administration by following T cell dynamics and performing
vaccination post-CAR T cell infusion. Subsequently, we will use these novel CAR T cells as tools to dissect the
role of PD-1 in reservoir dynamics during ART. We will compare temporary and continuous depletion of total PD-
1+ as well as PD-1+ CD4+ T cells. Specifically, it is of interest how PD-1 depletion will affect the latent reservoir
in terms of SIV intact proviral genomes. This project has the potential to substantially advance the utility of CAR
T cells to dissect the pathology of SIV/HIV and reservoir dynamics in the nonhuman primate model to study the
specific role of PD-1 during ART. It will inform and provide new strategies and targets for an HIV cure.

Public health relevance
Project narrative PD-1 is a well-characterized marker of the latent SIV/HIV reservoir with PD-1+ CD4+ T cells enriched for intact provirus. In previous work we demonstrated rapid and prompt depletion of T follicular helper cells and associated viral replication in nonhuman primates but increased extrafollicular viral replication due to depletion of PD-1+ CD8+ memory T cells. This proposal describes a drug-controlled second-generation anti-PD-1 CAR T cells which evaluates the effects of intermittent versus continuous PD-1+ cell depletion during antiretroviral therapy on immune function, intact provirus frequency, and reservoir dynamics.